Core A - Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The Administrative Core will provide administrative and secretarial support for all
activities of the Center. Dr. Diamond as Director of the Program will supervise this
Core. Ms. Nina Rey will be administrator for this program. Ms. Sylvia Jones will be
administrative assistant for the Program. Both will be funded primarily by the
Feinstein Institute as tangible evidence of the Institute's commitment to the Program.
The Administrative Core will provide administrative and secretarial support for all
three projects and for the two scientific cores. Ms. Rey will oversee budgets, and
address regulatory compliance. Ms Jones will assist with manuscript preparation and
progress reports, organize work-in progress meetings, meetings with collaborators.
She will organize the visits of external scientists who will review the research
progress.

Public health relevance
PROJECT NARRATIVE – Administrative Core This Core will help with the coordination of all aspects of the research except the experimental work.